Identification of novel MDR antimicrobials from human microbiome symbioses

Project 3
Project Summary
The human body is host to, and interacts with, a complex and dynamic community of microbes called the
microbiome. One critical function of the human microbiome is to help protect its host from infection. In
project three, we will identify members of the microbiome that can produce antibiotics that are active
against drug resistant pathogens and safe for human use. Through the use of genomics, we predict that
the human microbiome has the capacity to produce thousands of bioactive natural products that have
not been characterized. At UW-Madison, we have several large and ongoing human microbiome studies
that provide us access to thousands of samples from diverse populations of people for the isolation and
screening of new antimicrobial molecules. We will isolate microbes derived from the human microbiome,
determine their antimicrobial activity against Gram-negative and fungal pathogens, and apply our
genomics and metabolomics approaches to predict molecules with new chemistry. Our project goals
contribute to the mission of the Wisconsin Antimicrobial Drug Discovery and Development Center aiming
to develop new therapeutics in response to the growing antimicrobial resistance crisis.

Public health relevance
Narrative Project 3 The number of infections by multi-drug resistant pathogens is growing at a pace that far exceeds the development of new antibiotics. We propose to identify antimicrobials made by human symbiotic microbes from diverse populations, and to develop them into therapeutic drug leads. Our innovative approach, spanning discovery through pre-clinical testing facilitates rapid development of efficacious drug leads.